Developing mouse models for functional studies of locus-specific DNA methylation

PROJECT SUMMARY
The importance of DNA methylation in human health and disease is clear. The fundamental role of DNA
methylation in normal development and disease processes, however, remains elusive. The use of gene targeting
in animal models definitively demonstrated that genetic mutations at specific genes cause disease. An analogous
“epigenetic gene targeting” approach is urgently needed to advance the field of epigenetics and human disease.
In this regard, we developed the mouse model with an inducible CRISPR/Cas9 system for targeted manipulation
of DNA methylation in vivo. Our preliminary data demonstrated that this system provides unparalleled simplicity
in designing DNA methylation modifications or conducing epigenome engineering. Based on these findings, this
proposal responds to PAR-21-167: Development of Animal Models and Related Biological Materials for
Research. Our overall goals are to develop simple, robust, and reliable tools for targeted editing of locus-
specific DNA methylation; these will have broad utility in epigenetic research. Specifically, we will: 1− Utilizing
inducible dCas9-SunTagTET1 mice for precise targeted DNA demethylation. 2− Developing inducible dCas9-
SunTagDNMT3A-3L mice for targeted DNA methylation. The successful completion of the proposed studies will
open entirely new avenues in the field of epigenetics: investigators will be able to 1) test primary functional roles
of DNA methylation in vivo, 2) understand how DNA methylation modifications work together to cause biological
phenotypes, and 3) design and test targeted therapeutic approaches for epigenetic disorders. The epigenetic
gene targeting approaches we propose to develop will be widely utilized and accessible to a range of
investigators interested in functional epigenomics and human diseases.

Public health relevance
PROJECT NARRATIVE (Relevance Statement) Epigenetics refers to the study of mitotically heritable changes in gene function without accompanying DNA sequence alterations; of the three known epigenetic mechanisms, DNA methylation stands out as the most stable epigenetic mark. In this study, we will develop and validate novel animal models capable of modifying locus- specific DNA methylation in vivo. Completion of our proposal should enable the development of many new models for epigenetic diseases, and these will be enormously helpful in the ongoing search for new and improved strategies to treat human disease.